Diabetes and ObesitY research training in kENtucky (DOYEN)

ABSTRACT
The primary goal of the Diabetes and ObesitY research training in kENtucky (DOYEN) T32 program is to
prepare nationally competitive predoctoral students and postdoctoral fellows at the University of Kentucky for
careers spanning from basic research to community interventions in the field of diabetes and obesity research.
Having historically received low levels of support from NIH, Kentucky is an Institutional Development Awards
(IDeA) Program state and seeks to enhance research training that serves the unhealthy populations in the
Commonwealth of Kentucky. For much of the last 30 years, Kentucky has consistently ranked among the
nation’s five least healthy states. To address these disparities, DOYEN trainees who focus on clinical and
implementation research will have an unprecedented opportunity to investigate the often-understudied rural
communities unique to Kentucky. The need for highly trained scientists capable of conducting rigorous
research is critical given the increase in diabetes and obesity, both globally and in Kentucky. Integration of T0-
T4 diabetes and obesity research themes—spanning basic, pre-clinical/translational, clinical, implementation,
and population health—scientifically anchors the proposed program, which will challenge PhD students and
postdoctoral fellows to explore innovative concepts. The DOYEN program is scientifically unique within the
NIDDK T32 portfolio in that it leverages the research interests and strong funding portfolio of 20 experienced
Faculty Mentors, 7 emerging mentors, and a deep pool of talented trainees from 8 colleges and 7 biomedical
programs. Pre- and postdoctoral DOYEN trainees will gain valuable experience on their way to becoming
exceptional leaders in the research workforce. Research careers in this area are especially attractive to the
~25% of our trainees who originate from socioeconomically challenged areas of Kentucky, where diabetes and
obesity are particularly prevalent. The trainees that we recruit from this population will add diversity to the
program and the future biomedical workforce. The goals of the DOYEN program are to: 1) provide outstanding
trainees an innovative, multidisciplinary education that promotes essential and contemporary skills for
conducting rigorous and impactful research focusing on metabolic diseases; 2) support 4 PhD students and 2
postdoctoral fellows through stipends, travel funds, workshops, and individual development plans; and 3)
provide a critical mass of productive and established Faculty Mentors for T32 trainees, both one-on-one and in
teams, in a scientifically rigorous, broad-based, ethics- and diversity-sensitive environment. Individualized and
required training in rigorous experimental design, data science and quantitative analyses, team science,
scientific presentation and grant writing will provide program-specific enrichments for T32 trainees pursuing
mechanistic and intervention studies among the T0-T4 themes. Trainees who receive 1-2 years of training
through this multidisciplinary DOYEN program will develop world-class research skills that prepare them for
careers in innovative biomedical research that tackles complex disease processes in the diabetes and obesity
field.

Public health relevance
PROJECT NARRATIVE The proposed Diabetes and ObesitY research training in kENtucky (DOYEN) program represents a multidisciplinary, team-based approach involving multiple PIs to mentor predoctoral trainees and postdoctoral fellows in fundamental aspects of diabetes and obesity, translational science of diabetes, and advancement of therapeutics for diabetes. DOYEN will prepare these trainees to become independent investigators who are fully integrated in multidisciplinary diabetes research teams that tackle the challenges associated with the disproportionately high rates of diabetes and obesity in Kentucky.